Uncovering the role of RFT1 in growth and developmental signaling

PROJECT SUMMARY/ABSTRACT:
In the last 50 years, over 150 types of congenital disorders of glycosylation (CDG) have been described, while
available treatment options have severely lagged. CDG are early onset childhood diseases that often present
with severe symptoms that span most organ systems. Collectively, heterogeneity in the genetic causes and
clinical presentations of CDG have made treatment challenging, and thus, there is a significant need to elucidate
the mechanisms of individual CDG to provide available treatment options for patients. One CDG with no available
treatment and often severe symptoms is RFT1-CDG, caused by mutations in the transmembrane protein RFT1.
RFT1 is proposed to function in N-glycosylation and/or GPI-anchoring, however, its role in glycosylation remains
undefined. Many RFT1-CDG symptoms are related to defects in growth and development. My preliminary work
in C. elegans suggests that RFTH-1 (RFT1 homolog) may activate Hedgehog signaling, a key regulator of
development and growth, and that downstream signaling occurs through the pro-growth mTOR Complex 2
(mTORC2) pathway. Glycosylation can dramatically alter protein function or activity, and interestingly, multiple
Hedgehog signaling components are glycosylated. Thus, impaired developmental and pro-growth signaling may
underlie RFT1-CDG pathophysiology. This proposal seeks to investigate how RFT1 governs development and
growth via regulation of Hedgehog and downstream homeostatic signaling, as well as to deconvolute the role of
RFT1 in the glycosylation of Hedgehog signaling factors and establish how these events alter organismal
physiology. This work will be conducted using genetic, cell biological, and biochemical approaches in two
complementary model systems: C. elegans, to gain a whole organism perspective, and mammalian cell culture,
with the goal of translating our C. elegans work to understand the disease pathophysiology in humans. In doing
so, I aim to elucidate the mechanisms by which RFT1 mutations cause CDG-associated symptoms, while
establishing a framework to study other CDG types to inform the development of effective treatment options.
This research will take place at the University of North Carolina at Chapel Hill (UNC-CH) in the Rob Dowen Lab
as part of the Genetics and Molecular Biology (GMB) Curriculum. UNC-GMB upholds a collaborative, innovative,
and rigorous research program with excellent resources, outstanding facilities, and a substantiated commitment
to trainee success. In addition to building my scientific skillset through this proposed work, my training will include
strengthening my scientific communication and leadership skills to prepare for a career as a principal investigator.
Through GMB and its affiliated career development office, TIBBS, I will have abundant resources to hone these
skills. Additionally, my dedicated, interdisciplinary team of mentors, including my advisor and thesis committee,
will support both my scientific and career development training endeavors. Altogether, my scientific environment
and training plan will equip me to execute this proposal and become a well-rounded, independent scientist.

Public health relevance
PROJECT NARRATIVE: Mutation of the RFT1 gene causes a genetic disorder called a congenital disorder of glycosylation (RFT1-CDG) that results in severe symptoms that present at infancy and span most organ systems, producing major defects in growth and development. The biological function of RFT1 remains poorly understood, and hence, treatment options for RFT1-CDG are lacking. This project seeks to study the mechanism of RFT1 in regulating the growth and developmental signaling pathways that may contribute to the clinical presentation of the disorder and will inform treatment options for RFT1-CDG patients.